Quantitative Histomorphometric Risk Classifier (QuHbIC) in HPV + Oropharyngeal Carcinoma

SUMMARY: In 2016, nearly 50,000 adults in the US were diagnosed with oral and pharyngeal squamous cell
carcinoma (SCC), and nearly 10,000 died from the disease. Human papillomavirus (HPV) is now recognized as
the most common cause of oropharyngeal (OP) SCC in the US. Although concomitant chemo- and radio-therapy
is the most common treatment choice in patients with advanced OP-SCC, they have substantial short- and long-
term morbidity and result in increased health care costs in patients who are cured of their cancers. These patients
live with sometimes disabling morbidity for many years post-treatment. For these reasons, it has been suggested
that therapy in lower risk patients might be de-escalated. There is also a higher risk cohort of patients in whom
treatment with chemo-radiation may be insufficient, often resulting in distant metastatic failure. As such, these
patients may require intensified therapies to improve outcomes. This is an agonizing choice for patients and
their doctors, however. While patients do not want to be sickened by morbid treatments, they are obviously
concerned about having the best chance at cure. Unfortunately, there currently are no companion diagnostic
tools to identify which HPV + OPSCC patients are at (1) low risk of recurrence such that they can be treated
safely to high cure rates with de-escalated therapy; (2) higher risk of failure despite aggressive high dose
chemoradiation in whom treatment intensification strategies should be studied.
Recently, we developed a quantitative histomorphometric based image risk classifier (QuHbIC) that uses
computerized measurements of tumor morphology (e.g. nuclear orientation, texture, shape, architecture) from
digital images of H&E-stained tumor sections to predict progression in HPV+ OP-SCC patients; the current
version of QuHbIC has already been validated in >400 patients and found to be superior to clinical variables in
outcome prediction. In this Academic-Industry Partnership we seek to further improve predictive accuracy of
QuHbIC by incorporating new classes of image features relating to stromal morphology, density and patterns of
tumor infiltrating lymphocytes, and tumor cell multi-nucleation, features now recognized as promising markers of
unfavorable prognosis in HPV+ OP-SCC. We also seek to create a pre-commercial QuHbIC companion
diagnostic test that is ready for clinical use in risk stratification in p16+ OP-SCC. QuHbIC will be trained on >700
retrospectively identified HPV + OP-SCC whole tissue slide images with associated long term outcome data and
then validated on 440 cases from randomized, controlled, multi-institutional RTOG 0129 and 0522 clinical trials.
This partnership will leverage long-standing collaborations in (1) computational histomorphometry from
the Madabhushi group at Case Western Reserve University, (2) surgical pathology and oncology expertise in
HPV+ OPSCC from Vanderbilt University and the Cleveland Clinic and, (3) Inspirata Inc., a cancer diagnostics
company that will bring quality management systems and production software standards to establish QuHbIC
as an Affordable Precision Medicine (APM) solution for oropharyngeal cancers.

Public health relevance
Project Relevance: In this project we propose to optimize and validate a quantitative histomorphometric-based image classifier (QuHbIC) to better risk stratify survival among p16+ (Human papillomavirus (HPV)-related) OPSCC patients. The successful validation of QuHbIC could pave the way for its adoption as an Affordable Precision Medicine (APM) companion diagnostic tool, allowing for the identification of patients for whom therapies could be either "de-escalated”, left as standard, or even potentially escalated, depending on risk status.